VEGF VECTOR TO ISCHEMIC MYOCARDIUM W/DIFFUSE CORONARY DISEASE

The focus of this protocol is to evaluate the adenoviral delivery of vascular endothelial growth factor (VEGF) directly to ischemic myocardium. Objectives are (1) to determine the dose-dependent safety/toxicity of direct administration of the vector AdGVVEGF121.10 in the ischemic myocardium; and (2) to demonstrate whether direct administration of AdGVVEGF.10 to the myocardium will induce growth of collateral blood vessels, improve coronary blood flow and improve cardiac function in the region of the ischemia.